CORE--TISSUE CULTURE

The tissue culture core will provide a centralized facility for the purchase, preparation, testing, and dispensing of media and supplies necessary for the cell culture needs of the Program. In addition, multiple cell lines, both primary and established will be maintained. This will provide not only a cost effective alternative to individual purchase of supplies and reagents but will allow for a consistent source of cells, thus, fostering greater interactions between the projects.